Molecular Biology and Genetics of Human Tumor Viruses

OVERALL – PROJECT SUMMARY/ABSTRACT
Molecular Biology and Genetics of Human Tumor Viruses
Paul F. Lambert, PI
Viruses cause approximately 15% of human cancers. A viral etiology to a human cancer can have substantive
consequences on its treatment and prevention. For example, many virally-caused human cancers express virally
encoded products, which are potential targets for anti-viral, tumor-specific therapies. In addition, unique sets of
cellular genes and pathways contribute to virally-associated cancers, many of which are currently being pursued
as targets for anti-cancer therapies. This program project grant (PPG), now in its 45th year of continual funding,
has two major objectives: to use molecular biology and genetics to elucidate the life cycles of and transformation
by human tumor viruses and to translate this understanding into the identification of targets for specific anti-viral,
anti-tumor therapies. The PPG has seven lead investigators who share these research goals in studying multiple
human tumor viruses in two different virus families: papillomaviruses, and herpesviruses. Together, these
viruses cause the vast majority of virally-associated human cancers. The PPG has been highly productive over
the current funding period with 88 studies published of which 33% involve two or more labs, reflecting on the
strong synergies arising from the PPG.
Our PPG has a unique organization in which each of four projects have two or more labs working together on a
common theme in human tumor virology. Cross-fertilization of ideas and expertise between projects is fostered
by having many of the seven investigators participating in multiple projects. This interactive and collaborative
organization has been highly fruitful over the current funding period in several regards. Firstly, each project has
been productive and has collaborated with other projects. Secondly, innovative new ideas and approaches have
arisen, many of which are now being used across multiple projects. Thirdly, the collaborative environment
created by this PPG has spawned new interactions that have brought additional expertise to the PPG. The
specific themes of this PPG are: 1) Characterize the Mechanism by Which Papillomaviruses Evade Host
Immunity; 2) Uncovering Mechanisms of the Lymphoid Oncogenesis of Epstein-Barr Virus and Kaposi’s
Sarcoma Herpesvirus; 3) Latent and Lytic EBV Infection in Epithelial Cells; and 4) Defining the Role of EBV in
DLBCL Pathogenesis and Identification of Therapeutic Targets. Three cores provide expertise in A)
administration, statistics and bioinformatics, B) instrumentation, microscopy and histology, and C) virus
engineering and production.

Public health relevance
OVERALL – PROJECT NARRATIVE Viruses contribute to at least 21 different human cancers, representing approximately 15% of all human cancers. Understanding the biology of these human tumor viruses and how they cause cancer will provide new approaches for preventing and treating the associated cancers. In this program project grant a highly interactive group of seven investigators and their laboratory members engage in collaborative research focused on two objectives: to elucidate the life cycles of and transformation by human tumor viruses and to translate this understanding into the identification of targets for specific anti-viral, anti-tumor therapies.